Training Africans to Lead and Execute Neurological Trials & Studies (TALENTS)

PROJECT SUMMARY / ABSTRACT
Africa faces a growing burden of non-communicable diseases as the fastest growing cause of morbidity
and mortality, many of which are neurological disorders. Clinical studies are the foundation advancements in
medicine allowing scientists to test the efficacy and safety of a drug, therapy or strategy; and clinical
neuroscience research holds great promise to help mitigate the toll of neurological disease. However, the studies
that lead to discovery of causal /risk factors & drugs/interventions rarely emanate from African populations, which
bear a major brunt of neurological diseases. With the rise of precision medicine utilizing tailored interventions,
lack of race-ethnic diversity in generating evidence-based treatments can be a challenge if people of African
ancestry are to truly benefit from these targeted therapies. One way to bolster the limited pool of researchers in
Africa conducting neurological research and trials is to expose select individuals to coordinated education,
training, mentoring, & networking opportunities, thereby raising their odds of becoming successful clinical
researchers, thus creating a cadre of people on the continent making academic contributions to the overall field
of neurological diseases, including those conditions endemic to Africa. The goal of the Training Africans to Lead
and Execute Neurological Trials & Studies (TALENTS) program, is to build sustainable neurological research
capacity in Africa through partnerships between US and African organizations. Six scholars will be accepted into
the program each year and exposed to educational, mentoring, & networking activities. TALENTS Specific Aims
are: 1) To select & retain 24 promising multidisciplinary scholars from a cross-national pool) committed to careers
in neurological research; 2) To increase scholars' scientific knowledge, professional skills, motivation, &
credentials, in neurological research (Certificate Program, Master’s degree in Clinical Research, Think Tank
Sessions, and Scientific Conference events); 3) To enhance mentoring benefits and networking opportunities for
Scholars (congruent one-on-one mentoring approach and online networking activities); 4) By end of the grant
period to create an independent Master’s degree in Neurological Research at the University of Ibadan in Nigeria,
with several member of the faculty being recent TALENTS trainees; 5) To evaluate the effectiveness of the
Program. We anticipate that TALENTS will establish a sustainable network of individuals with expertise in
neurological research poised to assume leadership and academic faculty roles in Africa, and able to mentor
successive generations of locally well-trained and successful neurological researchers in the region.

Public health relevance
NARRATIVE The proposed program aims to develop and sustain capacity to conduct neurological research and impart such knowledge in Africa, by offering in-depth formal training in the design, execution, and leadership of neurological research to 24 carefully selected African scholars. The fellowship, administered through a collaboration between African and US academic institutions, as well as professional societies, will train eligible individuals in a broad range of clinical research issues, such that they can eventually populate Africa’s academic institutions as faculty, and foster enduring capacity to engage in high quality neurological research, and mentor future generations of Africans in the field.